Strengthening behavioral and social science research capacity to address the evolving challenges in HIV care and prevention in Uganda

Project summary:
The effectiveness of and increased access to antiretroviral therapy (ART) has resulted in longer,
healthier, and more productive lives for people living with HIV (PLHIV). However, this success presents
unexpected consequences of a growing population of people aging with HIV. Challenges of aging with HIV
include a high risk of co-morbidities, a double burden of intersectional stigma related to both aging and HIV,
and an accelerated aging process. Previous research has shown that older PLHIV are more likely to be
socially isolated. The intersection of HIV-related stigma and ageism is a complex issue requiring further
research on the design and feasibility of implementing stigma reduction interventions. There is also an
urgent need for research to address critical gaps in our understanding of the impacts of aging on the health
of PLHIV and the nature of the accelerated aging process in PLHIV. There is therefore a need to train the
next generation of researchers to address these challenges and to design, implement, and scale-up
tailored and context-specific interventions for the growing population of older PLHIV in Uganda and similar
resource-limited settings.
In the past 4 years, we have established a comprehensive research-training program at Makerere
University (Mak) with emphasis on strengthening leadership and expertise in Behavioral and Social
Sciences Research (BSSR-D43TW011304) to address the evolving challenges in HIV care and prevention
in Uganda. We have built on longstanding and productive collaborations between faculty at Mak and the
University of California San Francisco (UCSF), to provide a suitable environment for interdisciplinary
training in BSSR. We propose to continue the program and focus the next year and a renewal application to
address the challenges of HIV and aging. We propose a one-year supplement to spur interest in research
on HIV and aging and to obtain preliminary data to inform future long-term research training in this area.
Specifically, we aim to: 1) broaden the MakBSSR training program to include research training on HIV and
aging, ageism, and intersectional stigma, 2) provide research training and mentorship to masters and
postdoctoral fellowship trainees to address the evolving challenges of HIV and aging in Uganda and, 3)
prepare a renewal application of the MakBSSR research training program focused on aging with HIV,
ageism and intersectional stigma. This supplement will leverage existing resources of the MakBSSR
program including collaborations among social, behavioral, and biomedical scientists at Mak, collaborating
HIV programs, and partner universities in the USA. During the one-year supplement, we plan to train one
master’s degree candidate and two post-doctoral fellowship trainees, all at Mak.

Public health relevance
Project Narrative There is great need for research training on HIV and aging in order to address the challenges of the growing population of older People Living with HIV in Uganda and similar resource-limited settings. Leveraging our Makerere University based interdisciplinary research training program to strengthen behavioral and social science research expertise in HIV (D43TW011304), we propose a one-year supplement to spur interest in research on HIV and aging and to obtain preliminary data to inform future long-term research training in this area.